Vaccine-induced SARS-CoV-2-specific T cell responses in patients with X-linked Agammaglobulinemia

ABSTRACT
The SARS-CoV-2 pandemic has resulted in enormous loss of life and in long-lasting health sequalae in a subset
of convalescent patients. Little is known about the impact of SARS-CoV-2 infection on people with primary
immune deficiency diseases (PIDD). There is also a lack of guidelines regarding the inclusion of people with
PIDD in SARS-CoV-2 vaccination efforts.
Among PIDD, primary antibody deficiencies are most prevalent. X-linked agammaglobulinemia (XLA) is a genetic
disorder that is estimated to occur in 1 of 200,000 births and is caused by a mutation in Bruton tyrosine kinase
(BTK) that leads to an arrest in B cell development. Thus, XLA patients cannot mount antibody responses and
require lifelong therapy with gammaglobulin infusions to prevent infections. These infusions, however, do not
contain antibodies to the recently emerged SARS-CoV-2 virus leaving these patients vulnerable to COVID-19.
The currently approved SARS-CoV-2 vaccines are thought to mediate protection against infection through the
induction of neutralizing antibodies. However, all current SARS-CoV-2 vaccine candidates have the potential to
elicit humoral and T cell responses. Although T cell responses cannot protect against viral infection, anti-viral T
cell responses are critical in the control of virus replication and dissemination. In XLA patients, T cell responses
are considered to be normal. Thus, we hypothesize that the currently approved SARS-CoV-2 mRNA vaccines
will elicit persistent Spike protein-specific T cell responses with the potential to protect against disease against
the vaccine strain and variants of concerns. Support for our hypothesis is provided by data documenting that
XLA patients receiving the inactivated influenza vaccine can mount protective influenza-specific T cell responses
at a similar magnitude and quality as immunocompetent individuals. Aim 1 of the proposed studies will assess
magnitude, function, durability, and breadth of SARS-CoV-2 specific T cell responses in XLA patients prior to
and at week 1, week 3, 4 months and 1 year after vaccination and/or boost with one of the two approved SARS-
CoV-2 Spike protein mRNA vaccines. XLA patients, however, can encompass a broad spectrum of BTK
mutations. Some BTK mutations can inhibit Toll-like receptor signaling and other innate functions in monocytes
and dendritic cells. Both monocytes and dendritic cells are important in the priming and activation of antigen-
specific T cells. Therefore, Aim 2 of the proposed studies, will assess the function of monocytes and dendritic
cells in XLA participants and correlate these functional parameters to vaccine-induced T cell responses in the
same patient. To perform the studies, we will leverage well-established cohorts of XLA patients at Duke, UNC,
and USF. The results of our study are expected to inform health policies regarding the inclusion of XLA patients
in SARS-CoV-2 vaccination efforts and provide the foundation for larger studies with other PIDD populations.

Public health relevance
NARRATIVE Vaccine hesitancy and the emergence of new SARS-CoV-2 variants are major hurdles in the control of SARS- CoV-2 infection but is also impeded by the lack of specific vaccine guidelines for the inclusion of people with primary immunodeficiency disorders. Individuals with X-linked agammaglobulinemia lack B cells and antibodies, face recurrent infections, depend on lifelong gammaglobulin infusions, but maintain their ability to respond to most vaccines due to their intact T cell development. Therefore, we posit that XLA patients will benefit from mRNA SARS-CoV-2 vaccination through the induction of virus specific T cells that will prevent severe COVID- 19 outcomes.